Traffic-related air pollution exacerbates AD-relevant phenotypes in a genetically susceptible rat model via neuroinflammatory mechanism(s)

Project Summary
Alzheimer’s disease (AD) is the most prevalent age-related neurodegenerative disease in the
United States. More than 90% of cases are idiopathic and there is growing consensus that gene
x environment interactions influence the age of onset and progression of this devastating disease.
Epidemiological studies have reported a positive correlation between exposure to traffic-related
air pollution (TRAP) and the occurrence of the hallmark clinical characteristics of AD. Preclinical
studies support a causal relationship between TRAP and increased AD risk, but many of these
studies used concentrated ambient particles or diesel exhaust that do not recapitulate the
complexity of current real-world TRAP exposures. We have designed a unique exposure model
in which TgF344-AD rats expressing human AD susceptibility genes are exposed in real-time to
TRAP collected from a major freeway tunnel system, which preserves the gaseous and particulate
components of real-world TRAP and captures daily fluctuations in pollutant levels. We will
leverage this model to test our central hypothesis that TRAP decreases the time to onset and/or
increases severity of AD-like phenotypes via microglial cell activation secondary to lung
inflammation by addressing the following specific aims: (1) Determine which vehicle emission
component(s) cause neuroinflammation and neurodegeneration in the TgF344-AD rat; and (2)
Investigate the role of the lung-brain axis in mediating TRAP effects on AD phenotypes in the
genetically susceptible TgF344-AD rat. In Aim 1, male and female TgF344-AD rats will be
transported to the tunnel vivarium at 1 month of age and then exposed to gases, particulate matter
(PM), or both from light duty only vs. light and heavy-duty vehicle exhaust. Outcomes including
blood brain barrier (BBB) integrity, particulate matter in the brain, microglial and astroglial
activation, AD-relevant pathology, lung pathology, and spatiotemporal profiles of soluble
inflammatory mediators and immune cells in the lung, blood, and brain, will be assessed at 4, 9,
12, and 15 months of age. In Aim 2, we will assess the contributions of pulmonary inflammation
and microglial activation to TRAP effects on AD by quantifying AD phenotypes in TRAP-exposed
male and female TGF344-AD rats fed chow supplemented with pirfenidone or Senicapoc, which
block pulmonary fibrosis via inhibition of TGF-β signaling or inhibition of KCa3.1 ion channels,
respectively. Outcomes, which include cognitive behavior plus the endpoints measured in Aim 1,
will be assessed at 12 and 15 months of age. Our broad long-term objectives are to inform
regulatory and health interventions aimed at reducing AD risk for individuals living, working, or
attending school near busy roadways.

Public health relevance
Project Narrative Traffic-related air pollution has been associated with an increased risk for Alzheimer’s disease (AD); however, the vehicular emissions components responsible for this effect, and the mechanism(s) by which air pollution promotes AD remain largely unknown. To answer these questions, we will expose rats expressing human AD susceptibility genes in real-time to air pollution from a major freeway and compare the effects of gases vs. particulate matter from light vs. heavy duty vehicles on their lungs and brains, and determine whether lung inflammation leads to changes in the brain. These studies are needed to corroborate human studies linking traffic- related air pollution exposure to increased risk for AD, and to inform regulatory and health interventions to reduce AD risk for individuals living, working, or attending school near busy roadways.